Path B The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program under PAR-21-174

Project Summary
Project Title: Continued Implementation of a Produce Safety Program by the Maine
Department of Agriculture, Conservation and Forestry under Path B.
Project Description: This project continues our work to implement the Produce Safety Rule in
the state of Maine. It includes providing education, outreach and technical assistance to Maine's
produce farms, and performing regulatory inspections under FDA authority. This work will be
done under Program Path B. We will not be doing inspections for Subpart M - Sprouts.
Project Goals and Objectives: The Maine Department of Agriculture, Conservation and
Forestry will use federal funding under Path B to meet the project objectives identified in FOA
PAR-21-174. These include developing the necessary assessments, plans, and resourcing to
manage a mature program, implementing a cohesive education and outreach program; standing
up a complete regulatory inspection, compliance and enforcement program; and developing
incident response capabilities.
Expected Outcomes: We expect our project work to result in:
1. A comprehensive assessment of Maine's produce landscape, resource capacity, and
produce related event response capacity.
2. A live, current farm inventory.
3. A modern, efficient database for inventory and inspection functions that allows us to
perform program analytics and timely, accurate aggregate reporting.
4. A program structure that is appropriately sized and resourced to be effective.
5. A clearly mapped and developed compliance inspection program utilizing FDA
operational protocols and coordinating with FDA compliance structures.
6. A focused outreach and education program that partners strategically with others to
develop Maine's produce safety ecosystem.
7. A well-developed and implemented produce related event response program working
with FDA and other State partners.
More detail on our plans to achieve each of these is provided in the ME 2021-2026 Produce
CAP Project Plan.
Budget: $550,000 per year, totaling $2,750,000 over the 5 years of this CAP.

Public health relevance
Project Narrative The Continued Implementation of a Produce Safety Program by the Maine Department of Agriculture, Conservation and Forestry under Path B is a 5-yr project that will enhance produce safety by providing education and outreach to produce farms and implementing a consistent regulatory compliance inspection program for the Produce Safety Rule in the State of Maine. This project will fund efforts to reach all of Maine's produce farms to improve produce safety knowledge and practices in the state, and to develop produce safety practices specific to Maine's unique commodity groups. This work will be undertaken in cooperation with our FDA partners and other agricultural service providers in our state and region.